ANALYSIS OF MALABSORPTION IN PATIENTS WITH AIDS

The ongoing purpose of this project is to help elucidate the pathogenesis and effects of treatment of AIDS enteropathy and malabsorption using standard absorptive testing and D-xylose pharmacokinetics.